Nonalcoholic Steatohepatitis Clinical Research Network (NASH CRN)

Project Summary
Nonalcoholic fatty liver disease (NAFLD) and nonalcoholic steatohepatitis (NASH) ranks as one of the most
important causes of chronic liver disease in the United States, with 1 of every 3 adults and 1 of every 5 children
affected. NAFLD, especially NASH, is associated with increased liver, cardiovascular and cancer-related
mortality. The NASH Clinical Research Network (NASH CRN) was established in 2002 to conduct research
related to its clinical features, risk factors, pathogenesis, natural history and treatment in children and adults.
Over the last funding cycle, the CRN has accrued a comprehensive database of 4,544 patients from five
studies during the current funding period (to 1 Oct 18). Two clinical trials were completed (FLINT and CyNCh)
and The Losartan for Pediatric NAFLD (STOP-NAFLD) trial is underway with first patient randomized in Oct
2018. Additionally, the NASH CRN has archived a total of 504,685 biospecimens (serum, plasma, liver tissue,
DNA ad cDNA) in the NIDDK Biorepository, and 28,436 samples have been withdrawn for translational
research using the Ancillary Studies mechanism. Since 2004, a total of 31 publications have resulted from the
104 approved Ancillary Studies. Building on the success of the last funding cycle, the NIDDK has issued RFA-
DK-08-505 with the objectives of continue the NASH CRN for an additional 5 years. The objectives of the
NASH CRN during this next funding period are:
(a) to complete the network-wide studies initiated during the last funding period. These are two observational
longitudinal cohort studies (the Adult and Pediatric NAFLD Database 2 studies) and a randomized double blind
controlled therapeutic trial of losartan for NAFLD in children (STOP-CO, n=110). The NAFLD database may be
amended to meet additional outcome goals during the next funding period. These modifications may include
extending the length of follow-up of those enrolled, consideration of a follow-up liver biopsy in a subset of
patients, and expansion to include greater focus on cardiovascular, diabetes and cancer-related outcomes;
(b) to conduct new translational studies based on the clinical material and archived biospecimens from
previous funding periods including novel markers of autophagy, an important means of controlling cellular lipids
that is understudied relative to other lipid-regulating pathways in the liver and potential role in NAFLD disease
severity; and
(c) to conduct additional novel therapeutic studies in adults and children with NASH, such as the proposed
phase 2 study of amlodipine, as pro-autophagic therapy, in children and adults with NASH (AMPAT Trial).
Ancillary studies will leverage new collaborations (e.g. immunology, microbiome) to develop a comprehensive
model of NAFLD/NASH which will allow identification of adults and children at risk and establish effective
preventive and treatment strategies against NASH.

Public health relevance
Project Narrative Nonalcoholic fatty liver disease (NAFLD) affects one in three adults and one in five children in North America. Persons with NAFLD, especially NASH, are at increased risk of increased liver-, cardiovascular-, and cancer- related mortality. The NASH CRN aims to transform scientific discoveries from laboratory, clinical, and population studies into clinical applications to reduce the incidence and burden of adverse cinical outcomes due to NAFLD and NASH.